VS-CoBRE Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administrative Core of the Visual Sciences Center of Biomedical Research Excellence (VS-CoBRE) will
provide the infrastructure to support the career development of an evolving pipeline of scientists who will lead
investigations that impact visual disability. Resources will be focused on both current project leaders (PLs) and
the next generation of VS-CoBRE scientists following the current PL's graduation to independent funding.
Professional development and implementation of strategies for sustained productivity and growth of this
thematically aligned community of investigators will be enhanced by comprehensive mentoring, support of
relevant cutting-edge shared technology, initiation of a competitive peer-reviewed pilot program, and continuation
of focused recruitment around visual sciences research. The Administrative Core has six Aims to focus us on
meeting our objectives. Specific Aim 1: Prioritize holistic mentoring as a critical driver of investigator development
and independence. Specific Aim 2: Create administrative and fiscal oversight to provide robust support for visual
sciences research. Specific Aim 3: Implement a formative and summative evaluation plan to support progress
toward well-defined milestones. Specific Aim 4: Initiate a pilot program to support PL's leading emerging projects
focused on fundamental processes that affect the visual system. Specific Aim 5: Strengthen an environment that
promotes multidisciplinary research in visual sciences. Specific Aim 6: Leverage existing resources, including
those supported by IDeA programs, to amplify the impact of investments in visual sciences. The VS-CoBRE,
with the support of 1) mentoring teams; 2) the Internal and External Advisory Committees; 3) established IDeA-
supported initiatives; and 4) a robust Visual Function & Morphology (VFM) core, will provide an engaging
environment that promotes the success of the project leaders and their transition to independence.